A comprehensive binding and functional map of human RNA-binding proteins

Project Summary
The objective of the ENCORE (Encyclopedia of RNA Elements) project is to develop a foundational,
functional map of protein-RNA interactions of RNA binding proteins (RBPs) encoded in the human genome,
and the RNA elements they bind to across the transcriptome. These RNA elements, when expressed, form
the basis of co- and post-transcriptional regulation of human genes. Our strategy consists of developing and
integrating a physical map of 400 new RBPs in two diﬀerent human cell lines with transcriptome-wide
measurements of the eﬀects of depleting these RBPs. Over the past 9 years, our group has established highly
eﬃcient data production workﬂows of experimental methods that will enable us to immediately expand these
datasets further, which form a crucial and missing link to decipher the mechanisms of post-trancriptional
regulation and how these impact genetic variation and disease etiology. When combined with the data we
generated over the past 9 years, these eﬀorts will culminate in a comprehensive map of the functional RNA
elements recognized by essentially all RBPs expressed in two human cell lines, representing approximately
half of the known complement of human RBPs. ENCORE will continue developing and integrating a physical
map of hundreds of RBPs in two diﬀerent human cell lines with transcriptome-wide measurements of the
eﬀects of depleting these RBPs. In addition, we will provide training and outreach to establish ENCORE
annotations as the standard reference for co- and post-transcriptional research and clinical genomics eﬀorts
in the long-term. In summary, the data we will produce in this project will enable a more systematic and
comprehensive understanding of the role of RBPs and RNA biology in the contribution to human biology and
disease.

Public health relevance
PROJECT NARRATIVE The ENCORE (Encyclopedia of RNA Elements) project produces physical resources and datasets that form the reference annotation for RNA binding protein-RNA interactions in the human genome, providing a standard for insights into co- and post- transcriptional regulation in the short run, and consequences of expressed genetic variation in the long term, contributing to fundamental knowledge to benefit public health.